Near-Infrared Fluorescent Choline Kinase Inhibitors for Cancer Imaging and Therap

DESCRIPTION (provided by applicant): The aim of this research is to image the expression of choline kinase (ChoK) in breast tumors using near-infrared (NIR) fluorescent choline analogs capable of disrupting lipid metabolism in cancer cells. Breast cancer is the most prevalent cancer affecting women, and while many breast cancer patients respond well to the current standard of care, there are still subtypes of the disease resistant to existing therapies. Although early diagnosis improves the prognosis for these patients, there is a shortage of non-invasive methods to identify biomarkers associated with these malignant tumors. ChoK is an oncogene that is overexpressed in 39% of breast cancers, and is a marker of tumor aggressiveness. Increased ChoK expression is correlated with breast cancer tumor grade and the expression is inversely proportional to estrogen receptor status. A number of anticancer drugs specifically targeting ChoK have been produced. One of these inhibitors, TCD-717, is now being tested in Phase I Clinical Trials for treatment of advanced solid tumors. The development of methods to detect the expression of this oncogene in breast cancer would be highly significant for non-invasive staging of breast cancer status and for the identification of patients suited for ChoK-targeted therapy. Near-infrared (NIR) optical imaging is a relatively inexpensive technique that employs sensitive tracers, without the use of ionizing radiation, to report specific molecular interactions in vivo. The most effective known inhibitor of ChoK in animal models, MN58b, bears close structural similarity to the cyanine dyes, the major class of compounds that are used for NIR optical imaging. This project seeks to exploit this similarity to design NIR-fluorescent choline analogs that effectively inhibit ChoK at concentrations comparable to MN58b. Our prototype compound, JAS239, has a number of favorable characteristics: it enters cancer cells independently of the choline transporters, localizes to the cytoplasm where ChoK is normally expressed, accumulates in non-hypoxic regions of animal tumors, and is effectively reversed by salvage with excess choline. The proposed work will include synthetically fine-tuning the structure of the prototype NIR ChoK analog to optimize the inhibitory properties in vitro and bio-distribution in vivo. Using 14C-choline radio-tracing, NMR of live cells and cell extracts, fluorimetry, and confocal microscopy, the fluorescent choline analogs will be characterized for potency, NIR-fluorescence, and binding selectivity. The top candidates will then be assessed in murine breast cancer models with varying ChoK expression. The diagnostic potential will be explored using trace levels of each fluorophore, with the most specific probes expected to accumulate in the most aggressive tumors due to ChoK-binding. Higher-dose regimens will then be formulated, and tumor growth delay and animal survival measurements compared to MN58b.

Public health relevance
PUBLIC HEALTH RELEVANCE: The survival rate for breast cancer patients is improved substantially if the tumor is found early and confined to the breast. Invasive biopsies are usually required to determine tumor malignancy and plan treatment strategy, with toxic agents and harmful radiation used on patients who don't respond to anti-estrogen or anti-Her2/neu therapies. Our goal is the development of a single agent which can non-invasively report tumor grade and act as an alternative treatment for chemotherapy-resistant tumors. __SpecificAimsTextDelimiter__ Specific Aims This project will assess the ability of near infrared (NIR) fluorescent inhibitors of choline kinase (ChoK) to image ChoK expression in cancer cells. This application is based on the well-established observation that many cancers express high cytoplasmic levels of ChoK and on our observation that the most potent inhibitors of these kinases are structurally similar to existing near-infrared (NIR) fluorophores. Prototype constructs have been synthesized by modifying existing fluorescent molecules to bind to and inhibit ChoK. Synthesis of new NIR fluorescent molecules will now be performed based on the prototype constructs and existing ChoK inhibitors that have been shown to be effective inhibitors of tumor growth. Thus the synthesis of biomaterials that will exhibit both diagnostic and therapeutic potential is proposed. Elevated phosphocholine (PC), arising primarily from increased expression of ChoK, is one of the most common metabolic abnormalities in human cancer, occurring in 39% of breast cancers. Elevated PC forms the basis for detection of choline in human tumors by in vivo magnetic resonance spectroscopy (MRS). Inhibition of ChoK is sufficient to induce decreased proliferation and increased apoptosis in tumor models and indicates that the development of novel and selective inhibitors of ChoK is a desirable strategy for the treatment of cancer. The first Phase I clinical trial using a ChoK inhibitor (TCD-717) for solid tumor treatment began in 2011. I have developed prototype NIR-fluorescent ChoK inhibitors designed to preferentially accumulate within breast cancer cells at concentrations that inhibit choline phosphorylation and cellular proliferation. Thus, using a combination of optical and MR techniques it is possible to image both the expression and the metabolic products of ChoK in a single imaging session and to determine the effect of inhibitors on choline metabolism in vivo. In this application, I will extend these observations to measure the effects of the NIR choline inhibitors in vitro and in vivo in sophisticated breast cancer models in which the levels of ChoK have been genetically amplified or silenced. The key hypothesis to be addressed is that NIR fluorescent ChoK inhibitors can be used both to non- invasively image the expression of ChoK and slow the growth of cancer cells and solid tumors. ChoK inhibitors will accumulate within tumor cells expressing high levels of ChoK, allowing imaging at lower concentrations and the capacity to act as targeted therapeutics at higher doses. This hypothesis will be addressed by the following Specific Aims. Aim 1: Design and synthesis of NIR-fluorescent ChoK inhibitors. This aim will produce NIR-based ChoK inhibitors with which to test the hypothesis. Two approaches will be employed based on chemical modification of i) existing NIR fluorophores or ii) known ChoK inhibitors. Structure-activity studies will be performed to optimize the fluorescent properties and inhibitory action of these molecules. Aim 2: In vitro characterization of the synthesized probes. This aim will directly test the hypothesis using in vitro studies. This will include demonstration of cytoplasmic uptake, measurement of the kinetics of cellular accumulation, and characterization of ChoK-dependent retention. Aim 3: In vivo detection of choline metabolism and determination of therapeutic potential. This aim will test the hypothesis in vivo using relevant animal models. This will include measurement of probe delivery, bio- distribution and growth delay in orthotopic breast cancer tumor models with MRS and NIR optical imaging. The proposed inhibitors will provide in situ imaging agents to observe fundamental changes in cancer metabolism. At the conclusion of this project, 3-4 candidates will be selected for detailed studies of choline metabolism in animal models of cancer. It is also expected that 1-2 lead compounds will be identified suitable for future biodistribution, pharmacokinetic and toxicology studies to assess their potential for translation to human patients. Detecting choline metabolic changes using a dual modality MR and optical imaging approach will provide specific information that will be useful for the diagnosis and staging of tumors, to identify the subset of patients with high ChoK expression levels leading to poorer prognosis, and to predict the patient cohort suited for ChoK-targeted therapy.